Administrative Core

The Administrative Core will coordinate and oversee all research activities across KAPP-Sen TMC
Collaborative sites in support of SenNet goals towards mapping cellular senescence and its associated
secretory phenotype in the healthy human kidney, adipose tissues, pancreas, and placenta. Efforts will be
made to ensure ongoing robust and productive dialogue and input from KAPP-Sen TMC investigators and staff
with varied relevant areas of scientific expertise, disciplinary backgrounds, and perspectives. Moreover,
continued innovation will be pursued by leveraging the ability of investigators from across SenNet to provide
unique cutting-edge novel insights arising from their individual disciplines.
The Core will also participate in ongoing program evaluation using both informal strategies and the established
capacities of the UConn Center on Aging Evaluation and Population Assessment Research Core to perform
rigorous program evaluation throughout KAPP-Sen and of Sen-Net partners as a means of ensuring the
achievement of our objectives and pre-defined metrics, thus enabling optimal allocation of resources.
Core leadership and staff will also collaborate with NIH staff and other SenNet leaders in ensuring the
successful implementation of an innovative Phased Adaptive Approach to study design and data analysis,
thereby providing a rational path from an Initial Data Generation Phase to an Interim Evaluation and
Recalibration Phase leading ultimately to the Study Full Scale-Up and Completion Phase.

Public health relevance
PROJECT NARRATIVE OVERALL The Administrative Core for the U54 KAPP-Sen Tissue Mapping Center will work closely with NIH staff in providing integrated multidisciplinary leadership for the entire project.